Investigation of Neural Pathogenic Mechanisms Associated with Congenital Disorders of Glycosylation

PROJECT SUMMARY/ABSTRACT
Congenital Disorders of Glycosylation (CDG) are a group of rare genetic disorders that affect enzymes involved
in glycosylation, leading to altered or incomplete glycan structures. These enzymes also affect multiple pathways
in cells and tissues often leading to multisystem disorders that include neurological symptoms. Although several
studies have been performed to understand CDG at a molecular level, we still lack a clear understanding of
how inherited alterations in glycosylation result in the profound neurological features observed in CDG
patients. To answer this question, our multidisciplinary research teams will collaborate with each other and will
generate animal and cellular models that represent PMM2-CDG and PIGA-CDG including zebrafish models
(Project 1), drosophila models (Project 2) and 3D human cortical organoids as models (Project 3). The products
of PMM2 and PIGA genes catalyze early steps in N-linked glycosylation and glycosylphosphatidylinositol (GPI)
biosynthesis, respectively. The Proteomics/Glycoproteomics Core under the supervision of Dr. Akhilesh Pandey
at Mayo Clinic will perform in-depth quantitative proteomics and N-glycoproteomics analysis of these models
using latest generation mass spectrometers and optimized protocols for enrichment, fractionation and
peptide/glycopeptide fragmentation to evaluate the effects of these CDG on cellular proteome and glycosylation.
Notably, the Proteomics/Glycoproteomics Core is equipped with several automated sample preparation
platforms for robust and reproducible analysis. For proteomics analysis, a multiplexed quantitation approach
will be deployed using tandem mass tag (TMT)-labeling of peptides coupled to deep fractionation for optimal
quantitation and comprehensive coverage. This is made possible by combining real-time search functionality
with synchronous precursor selection and MS3-based quantitation of reporter ions on Orbitrap Ascend Tribrid
mass spectrometers. Highly innovative and relevant to this proposal are the deployment of size exclusion
chromatography (SEC) and mixed-mode strong anion exchange (MAX)-based enrichment for
glycopeptides and stepped collision energy HCD (sceHCD) and electron transfer dissociation with HCD
supplemental activation (EThcD) for more complete fragmentation of N-glycopeptides and glycans along
with site localization. The proteomics and glycoproteomics data will be analyzed by publicly available and in-
house developed scripts. The combined proteomics and glycoproteomics studies will be used to evaluate glycan
composition, glycan heterogeneity, their site of attachment to the proteins and site occupancy of proteins. We
believe that this approach has the potential to provide us the better molecular understanding of development of
neurological symptoms in CDG. Finally, the staff of the Proteomics/Glycoproteomics Core are highly
experienced and have previously collaborated and co-published with several other participating
investigators of this Program Project Grant ensuring the likelihood of success of this proposal.